Typhoid Toxin and Salmonella Typhi pathogenesis

PROJECT DESCRIPTION
Salmonella enterica serovar Typhi (S. Typhi) and the related serovar S. Paratyphi cause typhoid fever in
humans, a devastating disease that results in ~200,000 deaths every year. Although most of the cases occur
in developing countries, outbreaks occasionally occur in the United States. Unlike other Salmonella enterica
serovars, which can infect a variety of hosts and can cause limited gastroenteritis, S. Typhi is an exclusive
human pathogen and causes systemic, often lethal, disease. Despite its Public Health importance, the
mechanisms of pathogenesis of typhoidal Salmonellae remain poorly understood. Our laboratory has been
exploring the unique aspects of S. Typhi pathogenesis and devoted a substantial amount of effort to the study
of typhoid toxin, an A2B5 toxin that is highly conserved in typhoidal Salmonella serovars (i. e. S. Typhi and S.
Paratyphi), but that it is largely absent from non-typhoidal Salmonellae. Typhoid toxin is an atypical AB toxin in
that, unlike all known AB5 toxin family members, it has two enzymatically active subunits: an ADP ribosyl
transferase (PltA) with an as of yet unidentified host target, and a deoxyribonuclease (CdtB), which inflicts DNA
damage on intoxicated cells. These two subunits are covalently linked to one another and are associated to a
homopentameric B subunit composed of PltB. Typhoid toxin is uniquely adapted to humans as it recognizes
Neu5Ac-terminated sialoglycans on surface glycoproteins. Administration of typhoid toxin to experimental
animals can reproduce many of the acute pathognomonic symptoms of typhoid fever, including stupor and
lethargy, which most likely involve the central nervous system (CNS). Typhoid toxin exhibits a remarkable
biology in that it is only produced by intracellular bacteria, and after its synthesis and assembly, it is released
into the Salmonella-containing vacuole and subsequently transported to the extracellular space by specific
vesicle transport carriers. During the past funding period we have unraveled many mechanistic aspects of the
biology of typhoid toxin, including the description of its unique mechanism of intracellular expression, the
characterization of all the steps of its remarkable transport pathways, the discovery of novel bacterial protein
secretion mechanism, the description of its unique evolutionary history, and the discovery of an alternative
form of typhoid toxin. Finally, these studies have led to the discovery of a novel cell-intrinsic pathogen
restriction mechanism that prevents the replication of S. Typhi in mouse tissues and that it is antagonized by
the mouse pathogen S. Typhimurium through the activity of specific type III protein secretion effectors absent
from S. Typhi. These studies have raised very important questions related to pathogenesis of typhoid fever that
we intend to pursue during the next funding period.

Public health relevance
PUBLIC HEALTH RELEVANCE Salmonella enterica serovar Typhi (S. Typhi), the cause of typhoid fever in humans, continues to be a very significant health problem. Unlike other Salmonella enterica serovars, which can infect a variety of hosts and can cause food poisoning, S. Typhi is an exclusive human pathogen where it causes typhoid fever, a life- threatening disease. It is estimated that there are ~20,000,000 cases of typhoid fever every year, resulting in ~200,000 deaths. Although most of the cases occur in developing countries, outbreaks occasionally occur in the United States. There are no effective vaccines to protect against these infections. The studies proposed in this Grant application may serve as the foundation for novel therapeutic and prevention strategies against typhoid fever.